Are acellular vaccines driving the rise of pertactin-deficient Bordetella pertussis

PROJECT SUMMARY
Bordetella pertussis, the respiratory pathogen responsible for “whooping cough,” causes an estimated
24 million cases of vaccine-preventable illness per year, resulting in an excess of 200,000 deaths
annually. Importantly, the incidence of whooping cough in nations with high vaccine coverage is on the
rise and has been recognized by both the CDC and NIH as a priority (re)emerging infectious pathogen
of high concern. The flawed immunity conferred by acellular pertussis vaccines has been highly
implicated in the re-emergence of whooping cough. Although acellular vaccines are reasonably
effective in preventing severe disease, resultant immunity quickly wanes, and does not effectively
prevent asymptomatic colonization or transmission of B. pertussis from vaccinated hosts to susceptible
newborns. Rather than killed or attenuated bacteria, these vaccines are composed of 3-5 immunogenic
proteins, notably, pertactin, a bacterial autotransporter that is now disrupted or absent in 85% of
circulating strains in the United States. Bacterial adaptation in response to vaccine-driven pressure is
suspected to have selected for pertactin-deficient strains, which may enable the bacterium to evade
host immunity directed against pertactin. The high prevalence of pertactin deficient strains in the United
States is taken as confirmatory evidence, but there is little robust experimental evidence to support or
refute this hypothesis. More importantly, without clear experimental evidence, there is no consensus on
how to respond, leaving the CDC and NIH to launch workshops and panels to try to tackle and
understand the problem and consider possible solutions. Excitingly, we have developed a novel mouse
model of natural infection that allows us, for the first time, to directly address vaccine driven selection
for the loss of vaccine antigens, and here present preliminary data measuring the reduction in
colonization and bacterial shedding from the nares of pertactin-deficient Bordetella bronchiseptica, a
close ancestral relative of B. pertussis that naturally infects mice. Application of this model in
vaccinated mice has generated preliminary data indicating that pertactin-deficient strains have an
advantage in colonization and shedding from vaccinated hosts in comparison with wildtype B.
bronchiseptica. These data are consistent with the expectation that pertactin deficiency measurably
reduces fitness in unvaccinated hosts but increases fitness in vaccinated hosts. Therefore, we intend to
employ our innovative mouse model to thoroughly investigate the role and effect of pertactin deficiency
using representative isogenic B. pertussis strains. Together these experiments will provide the first
direct evidence to either support or refute the controversial explanation of vaccine-driven evolution of B.
pertussis, and thereby inform very different responses to the observed rise in incidence of disease and
prevalence of circulating pertactin-deficient strains in countries with wide vaccine coverage.

Public health relevance
PROJECT NARRATIVE Bordetella pertussis, the human specific etiologic agent of whooping cough, has reemerged as a pathogen of high concern with increased incidence following the implementation of acellular pertussis vaccines. Recently, up to 85% of circulating B. pertussis strains in the United States have been found to be deficient in pertactin, a putative autotransporter and one of the 3-5 antigens included in all acellular vaccines. We propose the following study using our novel mouse model of infection to provide the first direct evidence to either support or refute the highly speculated role of vaccine-driven selective pressure on pertactin-deficient B. pertussis, and the role of pertactin in infection of both vaccinated and unvaccinated hosts.